Collaborative Influenza Vaccine Innovation Centers (CIVICs): Component C: Clinical Core

To design, implement and manage ethical and statistically sound clinical trials and human challenge studies for influenza vaccines, vaccine components and delivery systems developed by the NIAID Collaborative Influenza Vaccine Innovation Centers. Current efforts include Phase I and Phase II clinical trials.